High Biocontainment (BSL4/ABSL4) core for replication competent virus work

Core C – Project Summary/Abstract
Core C provides support for high biocontainment work to Research Projects 1 (RP01), RP02, RP03 and Core
B. Work is prioritized through Core A. Core personnel bring unique expertise in molecular biology, cell biology
and animal disease modeling for Ebola and Marburg viruses. The core maintains virus stocks, makes
recombinant viruses, provides cell lysates and RNA from infected cells and ensures they are free of infectious
material, evaluates effects of host factor loss or overexpression on infection and performs work with transgenic
rodents. These core activities provide needed protein material and an understanding of subcellular structures
made after virus infection for RP01, are required for evaluation of virus protein function and genome stem loop
structures in controlling transcription for RP02, and provide detailed analysis of infection kinetics and host-virus
co-association for RP03. To directly address impact of host factors on virus protein production, virus RNA
transcription and the substructures formed by each, we have developed a novel protein-antibody + vRNA-FISH
based staining technique that is quantitatively assessed by automated microscopy image analysis. This
approach is expected to provide important information for the needs of each project and Core B. Core C also
works closely with Core B in production and evaluation of novel antibodies by providing purified virus lysates
and performing microscopy evaluation of staining of infected cells. The project distinguishes itself in providing
high-level molecular biology ability at BSL4 that will be used to produce recombinant viruses predicted to have
altered replication kinetics. Furthermore, use of transgenic animals, provided through Core B, will be used to
evaluate roles in controlling disease. In so doing, Core C provides the necessary processes to evaluate host
factor roles from cells through to disease that enables identification of potential targets for therapy development.